A Pilot Feasibility Study to Integrate PrEP into Emergency Departments using Decision Support Tools

Project Summary
Ending the HIV epidemic in the United States will require innovative strategies focused on both HIV prevention
and care. While pre-exposure prophylaxis (PrEP) is a highly effective biomedical intervention that can reduce
HIV incidence, uptake has been modest, particularly among groups at highest risk for acquiring HIV (e.g.,
MSM, young people, racial/ethnic minorities, and women of color). Barriers to successful PrEP initiation include
structural and individual-level issues as well as social determinants of health (SDoH). Innovative strategies are
needed to improve PrEP awareness, access, and uptake in venues that routinely care for vulnerable patients.
Emergency Departments (ED) serve as a safety net for underserved individuals that are unlikely to access or
engage in routine health services. Efforts to scale-up PrEP and expand its reach have included ED-based
PrEP prescribing, yet PrEP uptake, linkage to care and persistence have proven challenging. A focus on
application of evidence-based interventions using implementation science (IS) to strengthen PrEP delivery in
the ED and urgent cares (UC) to those who will benefit most has been limited to date. This project seeks to use
established IS methods to develop, validate, and pilot test a patient-centered Decision Support Tool (DST) to
promote PrEP persistence post ED/UC care. Based on the WHO SDoH framework, we seek to develop a DST
that can be administered in ED/UC settings and will assist PrEP eligible persons to identify their HIV risk,
promote self-efficacy, and provide support for SDoH needs identified through the tool. First, we will use pilot
data, previously validated tools, and evidence from the ED PrEP implementation landscape to design a patient-
centered PrEP DST using the Consolidated Framework for Implementation Research. We will then refine the
DST using a participatory prototyping workshop engaging current, prior and potential PrEP users. The DST will
be designed to optimize PrEP initiation, adherence and persistence post-ED/UC care by improving HIV risk
assessment, self-efficacy, and by identifying and addressing the multifaceted medical and social needs of the
individual patient. Next, we will determine the acceptability of the DST using the Normalization Process Theory
across EDs and UCs in the DC-Baltimore region. Finally, we will conduct preliminary effectiveness testing of
the DST among 120 PrEP eligible patients through a pilot implementation study at two EDs and one UC in
Baltimore and DC comparing PrEP prescription only to PrEP and the DST. The primary outcome will be 4-
month PrEP persistence; we will also measure PrEP linkage to care, initiation, persistence, and adherence at
1-week, 1- and 4-months using self-reported, clinical, and biological measures. This project aligns with NIH
and EHE priorities as it seeks to improve the PrEP continuum of care in two urban areas with high HIV
prevalence rates, reduce health inequities, and improve health outcomes. Implementation research will identify
factors that support successful implementation with the goal of using these data to improve PrEP uptake,
provide lessons learned, and seek to expand the program to other EDs both locally and nationally.

Public health relevance
Project Narrative This project will explore the development of a personalized decision support tool to assist with pre- exposure prophylaxis (PrEP) initiation and persistence among patients identified in the emergency department (ED) and urgent care setting. We will use a sequence of validated implementation science methodologies to develop and validate a decision support tool designed to optimize PrEP persistence by strengthening self-efficacy by addressing the multifaceted medical and social needs of the individual patient. We will then conduct preliminary effectiveness testing of this tool through a pilot stepped wedge implementation trial in two EDs and an urgent care in Baltimore, MD and Washington, DC among 120 PrEP eligible patients to determine PrEP initiation, linkage to care, persistence, and adherence rates.